PREPARATION OF A HIGH RESOLUTION GENETIC MAP OF HUMAN CHROMOSOME 3

A genetic map has been constructed for the distal portion of 3p. This map begins at DNF15S2 and extends to D3S22. The map is delineated by 9 polymorphic DNA markers. The distance covered by the map is about 75 centimorgans. About 100 new polymorphic DNA markers have been identified for this area. Fifty-one polymorphism screening membranes were prepared. Seventeen sets of filter membranes were prepared with the parents of CEPH families. One hundred and nine single copy 3q probes were tested; 45 of these 3q probes were found to detect DNA polymorphisms. Nine 3p probes were tested for frequency of heterozygosity with the parents of CEPH families.